Administrative Core

ADMINISTRATIVE CORE
PROJECT SUMMARY/ABSTRACT
The purpose of the University of Colorado Anschutz Medical Campus (CU-AMC) Diabetes Research Center
(DRC) is to catalyze and synergize diabetes research on campus. The Administrative core will provide
leadership, oversight and scientific direction for all aspects of the DRC to ensure it operates responsibly,
effectively and efficiently. Its mission is to facilitate a scientific environment that fosters interactive research and
resource sharing between the interdisciplinary DRC investigators. The DRC Director (Sussel) and Co-Director
(Reusch) will work closely with the internal and external advisory boards to provide oversight of the individual
biomedical cores to ensure they offer services that would be difficult for single users to implement in a cost-
effective manner, and would be of broad interest to the research base. In particular, the Administrative core will
work to leverage existing CU-AMC research resources and/or provide new resources, such that DRC
investigators have access to the most state-of-art technologies and instrumentation, specialized reagents and
resources for diabetes research, and training, with the intention of removing barriers that would potentially
impede progress in basic and translational diabetes discoveries. The Administrative component will be
responsible for overseeing all financial aspects of the DRC.
The Administrative core will also be responsible for the coordination, administration and promotion of the Pilot
and Feasibility and Enrichment programs. In particular, CU-AMC DRC Enrichment Program will enhance the
diabetes research environment at the University of Colorado Anschutz Medical Campus and its affiliates by
boosting the visibility, breadth and impact of diabetes research. The overall goal of this program is to position
the University of Colorado and the CU-AMC DRC, as a “destination” for faculty, students, patients, community
leaders and philanthropists, where support of cutting-edge diabetes research drives advancement of prevention,
screening, and treatment of diabetes and its complications.
The DRC Director and Co-Director will also represent the CU-AMC DRC at the NIH and on the national level.
Importantly, the DRC Director and Co-Director will work together to ensure there is a strong and responsive
leadership for the DRC programs at CU-AMC to ensure diabetes research in Colorado is maintained at the
highest level.